28th Annual United States Conference on HIV/AIDS (USCHA)

The 29th United States Conference on HIV/AIDS (USCHA) 2025, hosted by NMAC in collaboration with the University of North Carolina (UNC) Center for AIDS Research (CFAR), will focus on “Aging with HIV: Challenges and Opportunities for People Over 50”. Advances in HIV treatment have greatly increased the life expectancy of persons with HIV. Recent data suggests that of approximately 1.1 million people with HIV in the United States over 53% were aged 50 and older. This age demographic shift presents unique challenges and opportunities requiring focused attention and tailored strategies for intervention.
The specific aims of the conference are: 1) To advance scientific knowledge on the intersection of aging and HIV. 2) To enhance clinical practice and care for older adults living with HIV. 3) To promote policy and advocacy efforts that address the needs of older adults with HIV. 4) To foster community engagement and support networks for older adults living with HIV.
NMAC has a 30 year history of successfully drawing healthcare providers, state and local health department leaders, researchers, and people with HIV to participate in the annual USCHA. The average attendance at USCHA between 2022-24 was 3,000 persons. Given the critical and timely need to address the needs of people with HIV over 50, we anticipate similar or slightly higher attendance for the 2025 USCHA.

Public health relevance
“Aging with HIV: Challenges and Opportunities for People Over 50,” will provide a national platform for sharing the latest research findings on the intersection of aging and HIV, highlighting both challenges and innovative solutions. By bringing together researchers, healthcare providers (physicians, case managers, social workers, pharmacists), state and local health department personnel, and people with HIV, the conference will facilitate the dissemination of best practices and evidence-based interventions tailored to the needs of older people with HIV. Engaging with community members and older people with HIV will identify barriers to health and improve program effectiveness by giving a voice to those directly affected by programs and policies.